microRNA therapies for advanced brain tumors

ABSTRACT
Each year upwards of 14,000 patients are diagnosed with Glioblastoma (GBM), the most malignant form of
primary brain tumor. Surgical resection followed by radio and chemotherapies are the treatment options for
GBM, but patients generally succumb to the disease. MicroRNAs (miR) are emerging as key regulators of
cellular differentiation and proliferation; have been implicated in the etiology of a variety of cancers, including
GBM. Our exciting preliminary studies show great promise for exosomes shed from induced pluripotent stem
cell derived - neural stem cells (iNSC) expressing miR-124 to target brain tumors. In the mentored (K99)
phase of this study, I will evaluate the immune effects mediated by miR-124 delivered locally into the tumor
bed via encapsulated neural stem cells following tumor debulking. We hypothesize that miR-124 modulation by
exosomes enriched in miR-124 from NSC, when delivered into the tumor resection cavity will target tumor cell
proliferation and enhance T-cell mediated immune clearance of GBM cells. Once these effects are validated, in
the R00 phase of the award, the potential synergy between the modulation of miR-7 and miR-124, which target
AKT and STAT3 respectively will be studied to develop a sECM encapsulated iNSC delivered miR-7/ miR-124
therapeutic approach to target resected GBM. In order to ensure safety of iNSC implantation, the herpes simplex
virus – thymidine kinase suicide gene system will be incorporated. The efficacy of iNSC-miR-7/miR-124/HSV-TK
will be evaluated in mouse models of GBM resection. We hypothesize that dual modulation of miR-124 and miR-
7 will target the AKT-STAT3 signaling that is critical to tumor cell growth and together with the activation of host
immune system medicated tumor clearance will present therapeutic benefit. Upon validation, this microRNA
based therapeutic strategies will pave path to much needed novel treatments to target GBM.

Public health relevance
NARRATIVE This proposal emphasizes on evaluating the therapeutic potential use of induced pluripotent stem cell derived neural stem cells to deliver microRNA to advanced brain tumors. Once validated, this therapeutic strategy has a great potential to be integrated into the clinical care regimen for brain tumor therapy.